HAT-Dependent Control of Cardiac Fibrosis

Project Summary/Abstract
Fibrosis is defined as excess deposition of extracellular matrix (ECM), resulting in tissue scarring and organ
dysfunction. In the heart, fibrotic remodeling in the context of chronic comorbidities such as hypertension and
metabolic disease is associated with increased passive myocardial stiffness and the development of diastolic
dysfunction (DD), a contributor to the pathogenesis of a multitude of cardiac disorders, including heart failure
with preserved ejection fraction (HFpEF). The adult heart contains resident cardiac fibroblasts (CFs), which, in
response to stress, undergo a cell state transition to become activated fibroblasts, sometimes referred to as
myofibroblasts. Activated CFs are characterized by transcriptional reprogramming that results in enhanced
production and secretion of fibrotic ECM proteins. Despite the well-recognized roles of CFs in fibrotic remodeling
of the heart, there are no targeted therapies to prevent or reverse the phenotypic conversion of these cells into
an activated state.
Epigenetic regulatory proteins, including those that ‘erase’ (histone deacetylases [HDACs]) and ‘read’
(bromodomain-containing protein 4 [BRD4]) acetyl-histones, have clearly been shown to control of CF activation.
Acetyl-histone ‘writers’ (histone acetyltransferases [HATs]) have also been suggested to regulate ECM
production by CFs, but much of the prior work with HATs in the context of cardiac fibrosis was performed with
pharmacological tool compounds with suboptimal selectivity and potency profiles. Following up on a recent
phenotypic high-throughput screening campaign, our unpublished data reveal that highly optimized, drug-like
inhibitors of the p300 and CREB-binding protein (CBP) HATs profoundly and dose-dependently suppress
agonist-induced CF activation. Inhibition of p300/CBP catalytic activity with A-485, or neutralization of the acetyl-
histone binding bromodomain in these HATs using PF-CBP1, blocked transforming growth factor- (TGF-)-
mediated activation of cultured murine CFs through a SMAD-independent, non-canonical mechanism.
Additionally, inhibition of p300/CBP catalytic activity blocked CF activation and cardiac fibrosis in a mouse model.
Remarkably, A-485 and PF-CBP1 are also able to dramatically reverse constitutive activation of failing human
CFs, highlighting the translational potential of our findings. Mechanistically, we provide evidence to suggest that
p300/CBP inhibition squelches formation of activating acetyl-histone marks on gene regulatory elements and
results in transcriptional rewiring in CFs, at least in part, through inhibition of the forkhead box protein M1
(FOXM1) transcription factor. Three specific aims are designed to extend this new field of cardiac research and
test the overall hypothesis that inhibition of p300/CBP prevents and reverses the epigenomic and transcriptional
reprogramming that culminates in CF activation and pathological fibrosis of the heart.

Public health relevance
Narrative The proposed research is relevant to public health because developing novel treatment approaches for cardiac fibrosis and heart failure represents an urgent unmet societal need in the United States. Thus, the proposed research is highly relevant to the NHLBI’s mission to support medical research on heart failure, which affects ~6 million people in the Unites States and is a leading cause of mortality, hospitalization, and healthcare expenditures in our country. This proposed research is relevant to NIH’s mission to seek fundamental knowledge that will help to enhance health and reduce the burden of human illness and disability.